Conformal islet encapsulation for transplantation at vascularized sites to allow physiological insulin secretion

Project Summary:
Type 1 diabetes is an autoimmune disease that leads to selective destruction of insulin-secreting pancreatic b
cells and lifelong dependence on exogenous insulin supplementation. In the United States, type 1 diabetes
affects 1.84 million people, increased 21% in diagnosis between 2001 and 2009, and is projected to affect 5
million people by 2050. Allogeneic b cell replacement through intrahepatic islet transplantation leads to improved
metabolic control, quality of life, and decreased levels of long-term complications in patients with type 1 diabetes
compared to exogenous insulin supplementation. This is largely due to the capability of transplanted islets to re-
establish physiological glucose-stimulated insulin secretion. Recent clinical advances in islet transplantation
have increased the hope of the millions of patients with type 1 diabetes for a widely available cure. However, all
this progress notwithstanding, the need for chronic systemic immunosuppression to prevent allorejection and
recurrence of autoimmunity is still restricting the applicability of b cell replacement procedures only to the most
severe cases of type 1 diabetes due to the multitude of unavoidable side effects.
Islet immunoisolation through encapsulation with permselective biomaterials is a viable option to allow safer and
more widely applicable b cell replacement for patients with type 1 diabetes. The main challenges associated with
transplantation of encapsulated islets are (1) their large capsule size, which delays glucose sensing and insulin
release and results in an inability to achieve the same level of metabolic control as that provided by
unencapsulated islets, and (2) their large graft volumes, which prevent transplantation in retrievable, confined,
and well-vascularized sites. We developed an innovative microencapsulation platform that achieves conformal
coating of islets, including ones derived from stem cells, within biocompatible, stable, and clinically applicable
hydrogels that are only 10-20 µm thick. This conformal coating addresses limitations of traditional islet
encapsulation platforms and safety as demonstrated in non-human primate models of type 1 diabetes. However,
conformally coated grafts are still hindered by alloreactive T cell activation by alloantigen shedding through
permeable hydrogel capsules and can benefit from localized immunomodulatory therapies to improve their
performance for clinical translation. Thus, we propose to co-transplant them with our innovative nanomaterial
platform to achieve targeted and sustained release of drugs that decrease alloreactive T cell activation in the
site of transplantation (aim 1). As an alternative and innovative approach, we also propose to integrate islet
conformal coating with co-delivery of tolerogenic stromal cells that can present shed alloantigens to specific T
cells, thereby inducing anergy and deletion in the transplant site (aim 2). We will test these combination therapies
in murine and rat islet allograft models of type 1 diabetes in clinically applicable confined sites, uniquely enabled
by the small volumes of conformal coated grafts in aims 1 and 2. In aim 3, we will test the most promising
immunomodulatory approach in non-human primate islet allograft models and with human islets in a humanized
mouse model.

Public health relevance
Project narrative In the United States, 1.84 million people have type 1 diabetes with 21% increase in diagnosis between 2001 and 2009, and 5 million people expected to be diagnosed by 2050. Islet transplantation can cure type 1 diabetes, but it requires chronic systemic immunosuppression which limits the applicability of this procedure only to the most severe cases of type 1 diabetes. Our innovative platform for islet microencapsulation through conformal coating combined with our localized immunomodulatory approaches may eliminate the need for lifelong systemic immunosuppression and extend the applicability of islet transplantation to a larger number of patients with type 1 diabetes.